Impacts of Telehealth Policies on Inequities in Perinatal Behavioral Health Care Access and Outcomes

Project Abstract:
Suicide is now the leading cause of death during the perinatal period, and nearly a quarter of maternal deaths
are attributable to behavioral health (BH) conditions. As with maternal mortality and morbidity overall, poor
perinatal BH outcomes disproportionately affect historically marginalized communities of color. Despite the
prevalence and life-threatening nature of perinatal BH conditions, only 11% of individuals with these conditions
during pregnancy or postpartum receive needed care, and individuals from marginalized and under-resourced
populations are less likely to be screened or treated for BH conditions. Telehealth has enormous potential to
address the maternal morbidity and mortality crisis by improving access to perinatal BH care. It has been
shown to increase health care access and reduce missed appointments for BH care, particularly among
individuals from underserved communities. Research overwhelmingly finds comparable efficacy between in-
person and telebehavioral health (TBH) care. Finally, telehealth can help overcome particularly salient barriers
for pregnant and postpartum people. Few studies have examined TBH in the perinatal period, but evidence
suggests that TBH services for pregnant and postpartum people provide equivalent benefit to those delivered
in-person. Importantly, pregnant and postpartum individuals from historically marginalized populations, (e.g.,
Medicaid-insured; those living in rural areas; those with disabilities; and members of racial and ethnic minority
groups), face additional health care barriers, including structural racism, language barriers, and provider
shortages. The extent to which TBH diminishes or amplifies these specific barriers and reduces BH disparities
is unknown. Recently, the COVID-19 pandemic accelerated policy changes to make telehealth services more
widely available. However, state-level Medicaid policies are not uniform, and not all states retained pandemic-
era expansions in their reimbursement policy. As policies influencing availability of telehealth continue to
evolve, quantifying policy impacts on perinatal BH care access and outcomes, and better understanding the
mechanisms driving those impacts, are critical to using TBH more effectively to address maternal morbidity
and mortality from untreated perinatal BH conditions. To fill these gaps, this mixed-methods study will (1)
Develop a detailed, longitudinal dataset describing the evolution of state-level telehealth policies with relevance
to perinatal behavioral healthcare for individuals insured by Medicaid; (2) Use event-time modeling to estimate
the relationship between telehealth policies of interest and key behavioral health outcomes (e.g., emergency
department visits, overdoses, and suicide) and maternal-infant outcomes (e.g., maternal morbidity, preterm
delivery), with a focus on identifying inequities by race/ethnicity, rural residence, and disability status; and (3)
Apply the Consolidated Framework for Implementation Research in a series of in-depth interviews with patients
and providers to explain the quantitative findings through an examination of factors that influence telehealth
policy implementation and associated health outcomes.

Public health relevance
Narrative This mixed-methods study will examine the impact of state-level telehealth policies on perinatal behavioral health outcomes (e.g., emergency department visits, overdoses, and suicide) and maternal-infant outcomes (e.g., maternal morbidity, preterm delivery), overall and among historically marginalized populations. We will use event-time modeling, a quasi-experimental approach, to estimate the relationship between telehealth policies of interest and key outcomes, with a focus on identifying inequities by race/ethnicity, rural residence, and disability status; then apply the Consolidated Framework for Implementation Research in a series of in- depth interviews with patients and providers to explain the quantitative findings through an examination of factors that influence telehealth policy implementation and associated health outcomes. Study findings will be immediately actionable for providers, health system leadership, advocates, and policymakers seeking to improve perinatal behavioral health outcomes and address a preventable cause of maternal mortality.